From RRID to Resource Watch: A Knowledgebase of Biomedical Research Resources

Project Summary
The proposed GPU cluster will enable the RRID team to substantially improve detection of research resources
in the scientific literature, a task that is mundane but important for academic tool creators, including Shared Core
Facility directors, software tool authors, data resource owners, and the creators of biological resources such as
mice or antibodies. These resources are frequently nicknamed in the scientific literature, a practice that the RRID
project is aiming to eliminate, but one incentive for resource owners is to get better data about which papers are
using their tools.

Public health relevance
Project Narrative Research resources are not usually cited in the scientific literature, thus the mechanisms to assess which resource is more or less academically important simply do not work for scientists whose contributions to science are less traditional, such as software tools or mice. The RRID team has been using named entity recognition in the full text of papers to determine which research resources are used in which manuscripts. We propose to substantially upgrade these classifiers to improve recognition of these informal citations to assess usage and thus academic importance of research resources. For this we will train, tune and /or upgrade several classifiers that will improve the recognition of these non-traditional references and increased usability of the RRID data for resource creators.